University of Hawaii Cancer Center CCSG

OVERALL - ABSTRACT
The University of Hawai‘i Cancer Center (UHCC) is dedicated to reducing the cancer burden in Hawai‘i and the
U.S. Affiliated Pacific Islands (USAPI) through research, education, patient care, and community outreach,
emphasizing the unique ethnic, cultural, and environmental characteristics of the region. Our comprehensive
approach is rooted in the unique ethnic and racial diversity of our catchment area, which is distinguished by
cancer health disparities, geographic isolation, socio-economic challenges, medical provider shortages
(especially in rural or isolated areas), an aging society, rich environmental biodiversity, and a history of
traditional medicine. These unique characteristics drive our efforts, enabling us to define research priorities,
develop interventions targeted for these unique populations, and promote cancer health equity for racial and
ethnic groups specific to our catchment area. Our work impacts the local community and addresses cancer
challenges in the broader Pacific region, making UHCC a vital hub for cancer research, control, and public
health policy in this underserved geographical area. To achieve our mission, UHCC is organized into two
Research Programs: Population Sciences in the Pacific (PSP) and Cancer Biology (CB). Each Program
combines exploration of basic cancer mechanisms and etiologies for targeted interventions, facilitating the
translation of discoveries into cancer prevention and treatment applications for our diverse population. Our
commitment to innovative research is evident through our funding base of $15 million in peer-reviewed
funding, with 60% from the NCI. Collaboration is at our core, with 37 Members in PSP and 40 in CB,
fostering an exceptional level of intra-programmatic, inter-programmatic, and inter-institutional research
collaborations and publications. Five vital Shared Resources support our research goals: Analytical
Biochemistry, Biostatistics, Genomics and Bioinformatics, Nutrition Support, and the developing Body
Composition Lab. Our Research Programs, Community Outreach and Engagement (COE), Cancer
Research Training (CRT) initiatives, and clinical trials prioritize cancers that are causes for concern in our
catchment area while driving our Plan to Enhance Diversity through institutionally aligned Diversity, Equity,
and Inclusion (DEI) strategies. Our unique community-network-based clinical research enterprise provides
access to cancer clinical trials for over 70% of the Hawai‘i population through a UHCC-led affiliation of four
health systems. Our impact also extends beyond our immediate region through cancer prevention activities
across the Pacific, including partnerships with the University of Guam and others. This collaborative approach
has influenced cancer control policy in the State and the USAPI, underscoring the significance of UHCC in the
region. By leveraging the unique ethnic, cultural, and environmental attributes, we pioneer innovative solutions
for reducing the cancer burden, which leads to promoting health equity, fostering diversity, and advancing
cancer research that is impactful for our community and beyond.

Public health relevance
OVERALL – PROJECT NARRATIVE The University of Hawai‘i Cancer Center (UHCC) is dedicated to pioneering cancer research tailored to the distinct ethnic and cultural characteristics of Hawai‘i and the Pacific. Through a blend of innovative research, clinical trials, and robust community outreach and engagement, UHCC prioritizes underserved groups like Native Hawaiians and Pacific Islanders. Supported by many stakeholders, including State and Federal sponsors, our mission is to transform cancer care, emphasizing diversity, equity, and inclusion, ensuring Hawai‘i and the Pacific lead in globally impactful cancer discoveries.